Sex Hormone Supplementation and Rotator Cuff Repair: A Preliminary Randomized Trial

Project Summary/Abstract
Rotator cuff tears (RCTs) are among the most common musculoskeletal complaints and are
becoming more common. These injuries cost the US health care system $5 billion dollars
annually. Prospective randomized and controlled studies have demonstrated that rotator cuff
repair (RCR) is indicated for small- and medium-sized tears. Over 500,000 RCRs are performed
in the US annually. However, after RCR, healing fails to occur in >25% of patients.
Understanding how to improve healing is a critical barrier to success. There is near universal
agreement that improving the biology of tendon healing is the key to improving healing. Our
prior research suggests Sex Hormone Deficiency (SHD, i.e. hypogonadism) plays a role in RCR
healing failure. The research described in the current proposal is the next step towards
translating our promising and compelling preclinical and laboratory findings into improved
clinical care of patients with RCTs. SHD can be treated with hormone therapy (HT), which is
widely utilized, well-tolerated, inexpensive, and FDA approved. Thus, we propose a phase II
study to test preliminary efficacy and feasibility. Within aim 1, we will estimate the preliminary
efficacy of systemic HT through a randomized, placebo-controlled, double-blinded clinical trial.
Hypogonadal men aged 40-80 with SHD will be included. Postoperatively we will evaluate: A.
RCR outcomes and B. RCR healing. We hypothesize that outcomes and healing will be better in
the HT group than the control group. Within aim 2, we will determine the feasibility of studying
systemic HT in the setting of RCR. Although there is extensive clinical experience with HT in
human males with SHD, there is almost none in a setting of RCR surgery. To determine the
feasibility of a future, larger, multi-center, randomized clinical trial, we will measure the following
within the context of the study described in Aim 1: A. recruitment and retention rates, B. patient
compliance, C. hormonal response, and D. adverse effects. The expected outcome of the work
proposed is demonstration of the preliminary efficacy and feasibility of HT in human males with
SHD undergoing RCR. If this intervention is effective and feasible, then a future, larger, well-
powered, multi-centered randomized clinical trial with longer follow-up would be warranted.
Such a study could improve the treatment of people with RCTs, thereby decreasing a source of
significant disability.

Public health relevance
Project Narrative Shoulder tendon tears are a common cause of shoulder pain and disability and after surgery the repaired tendon often does not heal. In this pilot study, men with low sex hormone levels will be randomly assigned to receive sex hormone therapy or placebo pills while healing from tendon repair surgery in their shoulder. Sex hormone therapy increases sex hormone levels, and the investigators will test whether these increased sex hormone levels show promise in improving tendon healing and patient shoulder function and pain.